Mechanisms for GH action on epithelial cells

PROJECT SUMMARY
Accumulated damaged DNA, if left unrepaired, may disrupt tissue homeostasis, enabling a milieu favoring
tissue degeneration, cancer, and metabolic dysfunction. DNA damage response and repair pathways are
attenuated with aging and may also result in cell senescence, with senescence-associated secretory phenotype
(SASP) promoting DNA damage and cell proliferation in neighboring cells, or in apoptosis. Non-pituitary growth
hormone (npGH), synthesized locally in peripheral tissues, is recognized by the widely expressed GH receptor
(GHR), and acts through autocrine/paracrine mechanisms. Our preliminary results show that npGH is induced
by DNA damage in aged human colon tissues, in induced pluripotent stem cell (iPSC)-derived human colon 3D
organoids, in hypophysectomized rat colon lacking endocrine GH, and in senescent colon cells. In turn, npGH
suppresses DNA repair, further reinforcing DNA damage and resulting in chromosomal instability. We propose
a novel hypothesis supporting the role of local epithelial GH as an adverse determinant of age-associated DNA
damage accumulation and as a marker of epithelial aging.
We will assess npGH induction and DNA damage in aged colon organoids, and Colon Intestine-Chip
microfluidic devices. We will examine npGH expression in human colon tissue specimens derived from age-
determined cohorts, assess spatial genomic profiles in conjunction with cells expressing npGH, and elucidate
npGH as a cause of chromosomal instability. We will explore signaling mechanisms for npGH regulation of DNA
damage response activity, senescence pathways, and DNA damage repair. Epithelial GHR signaling in vitro will
be blocked with the GHR antagonist pegvisomant, a JAK2 inhibitor, and metformin. We will assess npGH actions
in aged tissues derived from colon-specific and universal GHR knockout mice, and in GH overexpressing
transgenic mice, and also assess npGH paracrine effects on colon epithelial somatic copy number alteration
(sCNA) and respective genes affected by sCNA. We will study whether npGH is expressed in senescent cells, and
whether it affects adjacent cell DNA damage and senescence. We will test paracrine npGH effects on senescence
in Colon Intestine-Chip devices co-cultured with human colon fibroblast npGH transfectants, and will confirm
in vitro results in transgenic models overexpressing GH or in GHR knockout mice.
We largely focus on validated human colon epithelial models, yet experiments in this proposal are designed
to elucidate a universal mechanism whereby local npGH reinforces epithelial age-associated DNA damage
leading to tissue degeneration and or neoplasia.

Public health relevance
PROJECT NARRATIVE DNA damage induces expression of non-pituitary colon GH, which, in turn, attenuates DNA repair pathways, yet accumulated epithelial DNA damage may enable an aging milieu favoring tissue degeneration, cancer, and metabolic dysfunction. We will use induced pluripotent stem-cell derived human colon organoids, normal human colon cells, and genetically altered mouse models to test the hypothesis that induction of local epithelial GH suppresses DNA damage response, reinforcing DNA damage. We propose a novel hypothesis whereby local epithelial non-pituitary GH is an adverse determinant for DNA damage accumulation and acts as an epithelial aging marker.